A VP4-Based Pseudovirus Nanoparticle Rotavirus Vaccine for Oral Immunization

Abstract
Rotaviruses (RVs) cause severe diarrhea in young children. The current live RV vaccines show reduced efficacy
in low- and middle-income countries (LMICs), ranging from 40% to 60%. Consequently, RV infections continue
to claim ~130,000 lives annually and cause enormous morbidity, calling for a new generation of RV vaccines
with improved effectiveness. Reasons for the diminished vaccine efficacy in LMICs include several factors that
disrupt gut’s health and reduce the replication capacity, and thus the efficacy, of live RV vaccines. In response
to these challenges, a non-replicating RV vaccine presents itself as a viable option for enhancing effectiveness
in LMICs. To address this need, we have invented pseudovirus nanoparticles (PVNPs) named S-VP4e. They
consist of a calicivirus inner shell and multiple RV spikes (VP4e) on the surface. The exposed RV spikes formed
by VP4e facilitate RV attachment and entry. Antibodies elicited by natural RV infections are largely specific to
VP4e and are predominantly neutralizing and protective, supporting VP4e as an ideal vaccine target. The
bioengineered S-VP4e PVNP is self-assembled, easily produced, stable, highly immunogenic, and protective
against diarrhea caused by RV challenge, making it an excellent RV vaccine candidate. Furthermore, the non-
replicating nature of the PVNP will bypass the replication issue of live vaccines and avoid the intussusception
risk associated with the replication of live RV vaccines, ensuring better efficacy and safety. Additionally, its low-
cost production offers improved cost-effectiveness for LMICs. As a proof of concept, we have demonstrated that
a trivalent vaccine comprising three S-VP4e PVNPs, representing the three predominant RV P types (P[8], P[4],
and P[6]), elicited high and balanced neutralizing antibody titers against the three major RV types after
intramuscular injection. Moreover, it effectively protected mice from diarrhea caused by challenge with RVs. In
this application we will evaluate the trivalent PVNP vaccine for oral administration, using U-Omp19 as an
adjuvant to enhance mucosal immunity. U-Omp19 is a protease inhibitor that protects vaccine antigens from
degradation in the gastrointestinal tract while triggering vaccine specific mucosal immune responses. The safety,
immunogenicity, and protective efficacy of the PVNP vaccine will be assessed using both mouse and highly
relevant gnotobiotic (Gn) pig models. This non-replicating PVNP vaccine with broad protection represent an
excellent candidate for the next generation of RV vaccine. The outcomes of this project will demonstrate the
vaccine's utility and provide crucial data for advancing human clinical trials. Two major lines of experiments will
be conducted. First, we will assess the PVNP vaccine for its cross-P type mucosal and systemic immune
responses, neutralization, and protective efficacy in mice after oral administration, using U-Omp19 as an
adjuvant. Second, the mucosal and systemic immune responses and protective efficacy of the vaccine will be
evaluated in Gn pig human RV challenge models. With strong preliminary data and an outstanding track record
of the research team, we are well-positioned to successfully achieve the goals of this application.

Public health relevance
Narrative: Despite the implementation of current vaccines, rotaviruses still cause approximately 130,000 deaths of young children each year, along with significant morbidity and enormous economic losses. This underscores the urgent need for an improved rotavirus vaccine. This project aims to develop our innovative nanoparticles into a broadly protective non-replicating oral rotavirus vaccine, enhancing cost-effectiveness and safety to facilitate the global fight against rotavirus infection and disease.